Advanced genetic systems for Fusobacterium nucleatum in oral and extra-oral pathologies

PROJECT SUMMARY/ABSTRACT
Fusobacterium nucleatum (Fn) is a key member of the human oral microbiota, where it serves a fundamental
role as a bridge between early dental surface colonizers and microbes associated with mature plaque. However,
Fn has also been implicated as a causative agent in several oral diseases (periodontitis and oral squamous cell
carcinoma; OSCC) and extra-oral pathologies including colorectal cancer (CRC), appendicitis, osteomyelitis,
and adverse pregnancy outcomes such as chorioamnionitis, placental infections, and pre-term birth. Yet, despite
decades of clinical relevance across disease states and human niches, Fn remains almost entirely beyond the
power of modern genetics for fundamental interrogation of its physiology, metabolism, and pathogenesis.
Recently, our team demonstrated that the intratumoral microbiota, dominated by Fn, colonizes specific
microniches of human oral and colorectal tumors and contributes to tumor spatial and cellular heterogeneity.
However, a mechanistic understanding of how Fn has gained such a fitness advantage that it can predominate
in CRC to reach >80% relative abundance in tumors, but is absent within the healthy colon, is severely lacking
and represents a critical barrier to progress for therapies. This proposal objective, leveraging pan-epigenome
data from 158 distinct Fn strains including clinical CRC isolates, is to make Fn strains systematically tractable
and to use advanced genetic systems to interrogate its pathogenesis in the context of CRC. In Aim 1 we will
apply two state-of-the-art approaches (SyngenicDNA and Plasmid Artificial Modification) to tackle the inherent
issue of RM heterogeneity across Fn strains of diverse origin. We will design, construct, and validate Fn-
optimized genetic tools for transposon-based random mutagenesis (pFnTn), CRISPR-Cas9 targeted
mutagenesis (pFnCas9), and complementation studies (pHS30MCSyn). In Aim 2 we will construct a genome-
scale library of 100,000s of barcoded transposon mutants of Fna SB010, a clinical CRC isolate. Using this library,
we will define the essential genes of Fna, both those that are absolutely required for survival, and those that are
required in specific environments, including during colonization of GI tumors within the ApcMin/+ murine model of
CRC. We will also create an ordered library of individual mutants representing the non-essential genome for
validation of pooled results and further screening. Our multidisciplinary team brings together expertise in genetic
engineering, pangenomics, (PI Johnston), and the intratumoral microbiota, preclinical cancer models, host-
microbial in situ imaging (Co-I Bullman), in addition to extensive knowledge and experience in barcoded
transposon library construction, screening, and analysis as well as generation of arrayed libraries (Sub-PI
Huang). Completion of these aims will provide critical tools for interrogating Fn physiology, metabolism, and
pathogenesis. Our long-term goal is to discover new strategies to prevent or treat bacterial-associated cancers.
Moreover, these tools are broadly applicable and will be made openly available to advance research across
human niches, including oral, gastrointestinal, and urogenital disease states.

Public health relevance
PROJECT NARRATIVE Fusobacterium nucleatum (Fn), predominantly a member of the human oral microbiota, is implicated as a causative agent in several oral diseases (periodontitis and oral squamous cell carcinoma; OSCC) and extra-oral pathologies including colorectal cancer (CRC), appendicitis, osteomyelitis, and adverse pregnancy outcomes such as chorioamnionitis, placental infections, and pre-term birth. Yet, despite decades of clinical relevance across disease states and human niches, Fn remains genetically intractable - almost entirely beyond the power of modern genetics for fundamental interrogation of its physiology, metabolism, and pathogenesis. This proposal’s objective is overcome this barrier to progress by making Fn strains, including clinical isolates, systematically tractable and to use advanced genetic systems to interrogate Fn pathogenesis in the context of CRC.